Exploring miR-29 in melanoma progression and prevention

PROJECT SUMMARY
The miR-29 family of microRNAs (miRNAs), consisting of miR-29a, miR-29b1, miR-29b2, and miR-29c, is
encoded by two miRNA clusters (miR-29a~b1 and miR-29b2~c) and has tumor suppressive properties in a
variety of human cancers. We found that, paradoxically, oncogenic BRAFV600E induces the transcription of both
clusters in melanocytes through either MAPK pathway activation (miR-29a~b1) or oncogenic stress-mediated
p53 activation (miR-29b2~c). This creates a barrier that prevents melanoma development, and we showed in a
genetically engineered mouse model that inactivation of the miR-29 family with a sponge construct promotes
melanoma progression. Interestingly, engineered human cell line models and human expression data from nevi
and melanomas show that melanoma progression is associated with decreased expression of miR-29b2~c.
Based on these findings we hypothesize that de-repression and overexpression of critical miR-29 targets
promotes melanoma development and that such targets are vulnerabilities of melanoma that can be exploited
for therapy. We have established a high-throughput genetically engineered mouse modeling platform to evaluate
the role of miR-29 targets in melanoma and to assess their potential as therapeutic targets. In this proposal, we
will extensively use this platform to first test if restoration of miR-29 expression and, thus, repression of all miR-
29 targets impairs melanoma development. We will further evaluate if silencing of a single miR-29 target elicits
significant effects on melanomagenesis. We have identified the oncogenic transcription factor MYBL2 as a bona
fide miR-29 target whose silencing reduces the aggressiveness of melanoma cell lines in vitro. We will test if de-
repressed MYBL2 mediates the effects of miR-29 loss by silencing MYBL2 in a melanoma mouse model driven
by miR-29 inactivation. Moreover, we will silence MYBL2 in a model with normal miR-29 activity to determine if
MYBL2 is a general vulnerability of melanoma. To ensure relevance to human melanoma, we will complement
these genetically engineered mouse models with experiments in human melanoma PDXs. Our proposed studies
will use our newly developed mouse modeling platform as a pipeline to systematically evaluate if miR-29 targets
in general, and MYBL2 specifically, have the potential to be further explored as therapeutic targets in melanoma.

Public health relevance
PROJECT NARRATIVE Inactivation of tumor suppressor miR-29 promotes melanoma through de-repression of its targets, and miR-29 targets may therefore represent vulnerabilities of melanoma. In this proposal we will investigate if repression of all miR-29 targets or specifically MYBL2, a miR-29 target critical for melanoma cell proliferation, opposes melanomagenesis in vivo. These studies will establish a high-throughput mouse modeling pipeline to systematically characterize the role of miR-29 targets and evaluate their therapeutic potential in melanoma.